Role of KLF6 in Lung Development

SUMMARY/ABSTRACT
Despite the lungs’ crucial role in health and disease, significant gaps remain in our understanding of the
mechanisms that govern the development of the normal, healthy lung. Adressing these knowledge gaps will
inform therapeutic options for disease and is vital for ensuring long-term respiratory health in both children and
adults. As a Pediatric Pulmonologist and physician-scientist, my long-term goal is to identify and validate new
therapeutic targets to improve the care of children with respiratory diseases. Toward this effort, our group
recently uncovered a novel regulator of lung development, Krüppel-like factor-6 (KLF6). In mice, my
preliminary data show that inactivation of Klf6 in the developing lung epithelium leads to a lethal lung growth
defect, and inactivation of Klf6 in alveolar epithelial type 1 (AT1) cells just after birth leads to a reduction in
lineage traced AT1s. Taken together, this suggests that KLF6 is required in distinct biological processes in
prenatal lung growth versus postnatal alveolar formation. By leveraging single-cell profiling, multimodal data
analysis and integration, and mouse genetic approaches, my overall objective is to 1) define the roles of
KLF6 in branching morphogenesis and postnatal alveolar formation, and 2) define the KLF6-regulated target
genes and signaling pathways. My central hypothesis is that KLF6 is a critical promoter of lung growth,
airway branching, and alveolar epithelial cell formation. By delineating the role and mechanism of a novel
transcriptional regulator in lung development, my findings will contribute to new strategies to address childhood
lung diseases such as bronchopulmonary dysplasia – a chronic lung disease in premature infants with lifelong
impacts on lung health. The central hypothesis will be tested by pursuing two specific aims: 1) Delineate the
mechanism of KLF6 function in lung growth during prenatal branching morphogenesis; and 2) Determine the
mechanism of KLF6 function in alveolar epithelium formation during postnatal alveologenesis. Mouse Cre lines
will be used to define the cellular mechanisms underlying the phenotypes observed, and sequencing-based
omics including state of the art 10X Multiome – simultaneous profiling of gene expression and chromatin
accessibility from the same nucleus – will be used to precisely define cellular states and their regulation. The
research proposed in this application is innovative, in the applicant’s opinion, because it will determine the
role of a poorly studied transcription factor regulator, KLF6, in lung development. The proposed research is
significant because it will provide the scientific premise
for my future R01 proposals to advance our
understanding of both normal lung development and disease pathogenesis.

Public health relevance
NARRATIVE The proposed research is relevant to public health because it focuses on defining the unexplored role of KLF6 in normal, healthy lung development. Elucidating the mechanisms underlying KLF6 function in lung development will offer valuable insights into pulmonary diseases and may provide opportunities to advance treatment approaches for lung diseases that impact individuals of all ages. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to seeking fundamental knowledge to enhance health and reduce illness and disability.